Acquisition of rodent metabolic and behavioral phenotyping system

PROJECT SUMMARY
The Arkansas Integrative Metabolic Research Center (AIMRC) is a Phase I COBRE at the University of Arkansas
at Fayetteville (04/01/2021-02/28/2026; PI: Dr. Kyle P. Quinn). The scientific objective of the AIMRC is to
investigate the role of cell and tissue metabolism in disease, development, and repair through research involving
advanced imaging, bioenergetics, and data science. The long-term objective of the AIMRC is to establish a
sustainable interdisciplinary research center that can support biomedical research at the U of A and grow the
emerging strengths in metabolic research on campus. The Bioenergetics Core currently assists researchers with
measurements of metabolic flux at the cell and isolated tissue levels. This supplement will add complementary
new capabilities by enabling non-destructive and automated monitoring of rodents to simultaneously monitor
body weight, oxygen consumption, carbon dioxide release, and water vapor formed during the kinetic activities
of these laboratory animals through the acquisition of Promethion metabolic cages. The instrument will enable
investigators to assess the unusual consumption/accumulation of heavy isotope enriched (13C/15N/2H)
metabolites formed under various disease conditions. The data acquired using the Promethion metabolic core
is expected to provide valuable information to understand the molecular mechanisms underlying various
diseases. The information gained from the Promethion metabolic core can be highly complementary to the data
acquired using the other available instrumentational facilities (Seahorse and Oroboros respirometers) available
in the AIMRC Bioenergetics Core. The Promethion metabolic cages purchased as part of this supplement
request will provide a unique resource to our campus and region. It will be highly beneficial for the research
proposed by current research project leaders and recruited new faculty who will be candidates for future
advancement to research project leaders.

Public health relevance
PROJECT NARRATIVE We propose to install Promethion metabolic cages for non-destructive, automated continual measurements of whole-body whole body oxygen consumption (VO2), carbon dioxide (VCO2), water vapor production rates. This instrument will provide innovative automated acquisition of high resolution synchronized metabolic and behavioral data on live rodents to aid ongoing and future research in our center.